EFFECTS OF TIMOLOL ON AQUEOUS HUMOR FLOW DURING NIGHTTIME SLEEP

To determine the effect of topically administered timolol on aqueous humor production in healthy sleeping subjects while they are infused intravenously with epinephrine at a rate comparable to the endogenous release rate of active hormone.